Orbitofrontal circuit mechanisms underlying alcohol use disorder

PROJECT SUMMARY
The orbitofrontal cortex (OFC) is a major hub in the brain that interacts with numerous other brain circuits to
control many behaviors related to learning, memory and decision-making. OFC has also emerged as a significant
node of dysfunction in alcohol use disorder (AUD). Nevertheless, how different OFC outputs contribute to AUD
remains largely unknown. One major challenge in such an investigation is that AUD develops over long time-
scales and is a chronic relapsing condition. Another challenge is that distinct projection outputs of OFC have
different functions. Thus, investigation into the neuronal mechanisms underlying AUD will benefit from a longitu-
dinal study of projection-specific neurons that spans the long timescale representative of AUD. Recent advances
in two-photon microendoscopic calcium imaging allows the longitudinal tracking of the same projection-specific
OFC neurons across months. In this proposal, we will use this cutting-edge technology to study the function of
two OFC circuits—projections to dorsal striatum (targeting the densest projection near the border between dorsal
and ventral striatum) and the ventral tegmental area (VTA) in alcohol related behaviors. These downstream
targets are themselves critical regulators of natural reward or alcohol related behaviors, and these projections
have been demonstrated to have at least some non-overlapping functions in natural reward learning. The central
question of interest in this proposal is whether the encoding adaptations during initial alcohol use in neuronal
ensembles within these OFC circuits predict their subsequent encoding and control of aversion-resistant operant
alcohol seeking or cue-induced reinstatement. In aim 1, we will image alcohol related neuronal activity weekly in
the above OFC outputs while C57/BL6 mice have intermittent access to 20% alcohol in a two-bottle choice
paradigm (IA20%2BC) for 7-8 weeks. We will test the hypothesis that OFC→dorsal striatum, but not OFC→VTA,
neurons strengthen their responses to alcohol, as animals begin preferring alcohol. In aim 2, we will longitudinally
track the same neurons from initial alcohol consumption to subsequent tests of aversion-resistant seeking. Spe-
cifically, we will investigate the role of the above circuits during operant self-administration of alcohol with or
without quinine adulteration, and test the hypothesis that the same OFC→dorsal striatum neurons that encode
initial escalation of alcohol preference also encode and mediate aversion-resistant seeking. In aim 3, we will
longitudinally track neurons from initial alcohol use to subsequent extinction and cue-induced reinstatement of
operant alcohol seeking. We will test the hypothesis that OFC→VTA neuronal activity predicts and mediates
cue-induced reinstatement of operant alcohol seeking. Overall, these studies will yield insights on the extent of
overlap of neuronal encoding of alcohol consumption/preference, aversion-resistant operant seeking, and cue-
induced reinstatement.

Public health relevance
PROJECT NARRATIVE This proposal is aimed at studying the role of OFC circuits in alcohol consumption and seeking. To this end, we will use cutting-edge imaging techniques to longitudinally image neuronal circuits in OFC. Completion of these aims will likely yield major insights into how a critical node of dysfunction in alcohol use disorder processes al- cohol consumption and seeking.